Mechanism of Yeast Transcriptional Regulators

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text. (No change from original)

Public health relevance
PUBLIC HEALTH RELEVANCE: A cell carefully regulates the transcription of each one of its many genes. In humans, abnormalities in this complex process (whether inherited or acquired) can lead to many diseases, including a variety of cancers. Plasticity in transcriptional circuitry s well documented in the progression of normal cells to cancer cells, and a deeper understanding of it will provide insights into recognizing and perhaps treating cases where it leads to aberrant physiologies.